Neuroimmune Genomic Profiling of Alzheimer's Disease

Summary
Molecular-genetic studies have illuminated the primary pathway of Alzheimer’s disease (AD). However, a
relatively long chronic prodromal period of the disease, and the cascade of molecular events underlying the
AD-associated synaptic and neuronal loss and neurodegeneration in the aging brain, have not yet been fully
elucidated. Aging is the most common risk factor contributing to the decline of both the immune system and
brain function.
Recently, we, and others, demonstrated that, surprisingly, the adaptive immune system is involved in
Alzheimer’s disease. As this is a newly emergent field, the molecular mechanisms of interactions between
adaptive immunity and AD remains unknown. We hypothesize that harmful populations of γδT-cells or brain-
infiltrating αβT-cells (CD8+ T-cells) responding to aberrantly expressed antigens in the brain contribute to AD
pathology. In our recent report and in our preliminary data, we found that the depletion of B-cells or T-cells (
CD8+ T cells) in AD model mice reduces AD-associated pathology. Although we, and others, detected the T-
cells in the human and mouse brain, the hypervariable immunogene TCR-repertoires and molecular identities
of populations of T-cells in the brain have not yet been determined. This implies that the origin and functional
connections of adaptive immune and brain cells remain unknown. We have developed and applied highly
sensitive assays to track TCR repertoires in AD patients versus controls. On the other hand, we found highly
increased epigenomic chromatin accessibility and upregulation of adaptive immune response genes (MHC
complex and other genes) in the neuronal and non-neuronal residential cells in the AD brain. We will apply
large-scale, innovative, high-throughput genomic technologies for the analysis of AD-mouse models and a
large collection of clinically characterized brain specimens from both AD and non-demented subjects. We will
conduct a molecular dissection of the neuronal- adaptive immune- genomic axis to identify novel integrative
factors contributing to AD pathogenesis or to the protection of brain neurons in the aging process.

Public health relevance
Public Alzheimer’s disease (AD) is a common chronic neurodegenerative disorder regarded as a highly significant public health issue. Neuroinflammation accompanies AD pathology, but the etiology for this disorder is not yet fully understood and, no treatment is available that can reverse or stop the neurodegenerative process in AD. In this study, we will apply ultra-sensitive genomic technologies for tracking immunogenetic and epigenomic profiles in AD patients and AD model animals that may provide paradigm-shifting findings and identify new types of biological markers and targets for the effective treatments of AD.